BRAIN AND TISSUE BANK FOR DEVELOPMENTAL DISORDERS

To systematically collect, store, and distribute brain and other tissues from research purposes. The tissues shall include those obtained premortem and postmortem from infants and children with developmental disorders and from normal controls who died accidentally.